Down Syndrome Memantine Follow-up Study: EEG Data Analysis and Data Sharing with the Research Community

ABSTRACT
Down syndrome (DS) is the most common genetically defined cause of intellectual disability and a major cause
of early-onset Alzheimer’s disease (AD)-type dementia. Recently, we concluded and published the results of a
randomized phase II trial of 16-week treatment with the AD drug memantine (the follow-up memantine trial) in
which we investigated the safety and efficacy of this drug on cognitive and adaptive test results in adolescents
and young adults with DS. This study was performed between May 13, 2015 and July 22, 2020. In total, 185
participants with Down syndrome were assessed for eligibility and 160 (86%) were randomly assigned either
memantine (n=81) or placebo (n=79), which makes it one of the largest clinical trials in the field of DS to date.
Participants (aged 15–32 years) with either trisomy 21 or complete unbalanced translocation of chromosome
21 and in general good health were recruited from the community at one site in Cleveland, Ohio, and another
in São Paulo, Brazil. Although the trial found no evidence of cognitive-enhancing effects of the standard dose
of memantine treatment in the study participants, hypothesis-generating, exploratory analysis in that work
pointed toward the need of memantine doses higher than those typically used in patients with AD to produce
significant cognitive-enhancing effects in healthy adolescents and young adults with DS. In addition to
information on drug effects, this study generated a comprehensive array of neuropsychological and clinical
data in a large and diverse set of individuals with DS. The trial protocol also included (as exploratory parallel
experiments) collection of evoked electroencephalographic (EEG) data to test auditory brainstem responses
and mismatch negativity before and after memantine treatment and quantification of plasma biomarkers of AD
at the final visit of the study. Here, we propose to perform analyses on the relationships between scores in the
various neuropsychological measures and the EEG and AD biomarker assessments and to share the de-
identified data with the community. Accordingly, this project has three specific aims: (1) Analyze the EEG and
plasma AD biomarker data generated in the follow-up memantine trial and study their relationship with scores
of neuropsychological assessments; (2) Build a comprehensive database of all clinical, neuropsychological,
electrophysiological, and biomarker data from the follow-up memantine trial; and (3) Contribute the database to
the NIH-funded INvestigation of Co-occurring conditions across the Lifespan to Understand Down syndromE
(INCLUDE) Project through the INCLUDE Data Coordinating Center (DCC). Transferring all the data collected
from the follow-up memantine trial will represent a significant contribution to Component 2 of the INCLUDE
project, which involves the “Assembly of a large cohort of individuals with Down syndrome across the lifespan
to perform deep phenotyping and study co-existing conditions.”

Public health relevance
NARRATIVE We recently concluded and published the results of a large phase 2 trial of 16-week treatment with the Alzheimer’s disease drug memantine (the follow-up memantine trial) in which we investigated the safety and efficacy of this drug on memory, thinking, and adaptive test results in adolescents and young adults with Down syndrome. In addition, the trial protocol also included collection of evoked electroencephalographic (EEG) data before and after memantine treatment and measurement of plasma biomarkers of Alzheimer’s disease at the final visit of the study. Here, we propose to perform analyses on the relationships between scores in the various neuropsychological tests and the EEG and Alzheimer’s disease biomarker assessments and to share the de-identified data with the community via the NIH-funded INvestigation of Co-occurring conditions across the Lifespan to Understand Down syndromE (INCLUDE) Project through the INCLUDE Data Coordinating Center (DCC).